Novel Integrative Analysis of Microbiome and Host Genetics in Childhood Asthma Research

Project Summary
Childhood asthma poses a significant public health burden due to its high prevalence, associated
healthcare costs, and long-term impacts on children's health and development. The human
microbiome has been associated with asthma phenotypes, endotypes, and disease severity,
positioning it as a potential therapeutic target for asthma prevention and control, particularly since
the microbiome is inherently modifiable. We recently assembled the largest and most
geographically diverse datasets containing infant nasal and gut microbiomes, along with host
genetics data, from multiple birth cohorts within the NIH-funded Children’s Allergy and Asthma
Data Repository (CADRE). This study presents a unique opportunity for a more thorough
investigation into the impact of the microbiome and its interactions with host genetics on asthma
risk. Unfortunately, the statistical and computational tools for analyzing the CADRE study are
currently lacking, primarily due to the complex compositional structure of microbiome data. This
proposal seeks to address critical gaps in the methodological literature by focusing on three major
areas. Specifically, we aim to develop a comprehensive suite of statistical methods to: (1) detect
host genome-wide associations with the infant microbiome; (2) identify genotype-microbiome
interaction effects on childhood asthma; and (3) uncover the causal role of the infant microbiome
in childhood asthma. These aims are grounded in rigorous prior research, underscoring the
significance of the scientific questions and the limitations or absence of existing methods. We will
apply these methods to the CADRE study. These methods have the potential to advance our
understanding of the microbiome's role in childhood asthma and facilitate the development of new
strategies for asthma treatment and control.

Public health relevance
Project Narrative Childhood asthma is a major public health issue, with significant long-term impacts on children's health and development. Within the context of the largest and most geographically diverse microbiome and host genetics datasets from the Children’s Allergy and Asthma Data Repository (CADRE), this proposal aims to develop novel statistical methods to enable robust and comprehensive understanding of the interplay between microbiome and host genetics and their implications for childhood asthma. This effort paves the way for developing new microbiome- based strategies for asthma treatment and management.